Intrinsically disordered domains of α-synuclein: effect of fibril formation and fibril polymorphs

Many high-resolution structures of the cross-β core of amyloid ﬁbrils have been solved using solid-state NMR and cryo-electron microscopy in recent years. However, most ﬁbrils important in neurodegenerative diseases, as for example α-synuclein (aSyn) ﬁbrils found in in Lewy body dementia (LBD) and other synucleinopathies, have sizable intrinsically disordered regions (IDRs) surrounding their ordered cross-β ﬁbril core. These IDRs are part of the ﬁbril surface, where they can interact with ﬁbril-speciﬁc binders and be important for ﬁbril toxicity. Therefore, determining the residual structure and dynamics of these IDRs, how they interact with other cellular components, and how they relate to ﬁbril toxicity is the next logical step in the LBD and Alzheimer’s disease related dementia (ADRD) ﬁeld. The goal of this proposal is to determine the conformational ensemble and dynamics of the IDRs from aSyn ﬁbrils important in LBD, ADRD and other synucleinopathies. The N and especially the C-terminus of aSyn are intrinsically disordered in the ﬁbril. These IDRs are binding sites for ﬁbril-speciﬁc interactors such as the co-chaperone DNAJB1. Our central hypothesis is that a speciﬁc ﬁbril core structure (polymorph) will determine the residual structure and dynamics of these IDRs and consequently the interaction with ﬁbrils-speciﬁc binders. The rationale of this research is that only complete molecular models of amyloid ﬁbrils that include their IDRs will allow us to determine polymorph-speciﬁc binding partners, which can explain the diﬀerence between LBD and other synucleinopathies. These complete molecular models will not only point to natural interactors, but also to disease-speciﬁc biomarkers and therapeutics for LBD as well as ADRD and other synucleinopathies. We will use a combination of solid-state NMR, EPR, and molecular dynamics simulations to test our hypothesis using three speciﬁc aims. Aim 1 is to determine the change in residual structure and dynamics of IDRs upon ﬁbril formation. Based on the known core structure and our conformational ensemble of the IDRs, we will create a model of the entire ﬁbril. Aim 2 is to determine the eﬀect of ﬁbril polymorphs on residual structure and dynamics of IDRs. We will show to what degree a speciﬁc cross-β core determines the conformational ensemble of its adjacent IDRs and determine the cytotoxicity of diﬀerent aSyn polymorphs and chimeras. Aim 3 is to determine the eﬀect of the ﬁbril core on aSyn-DNAJB1 interaction. Here, our hypothesis is that ﬁbril formation increases the accessibility of the DNAJB1 binding site and that some ﬁbril cores found in LBD and other synucleinopathies do this better than others. These aims will (i) determine the changes in the IDRs outside the ﬁbril core upon ﬁbril formation and result in a whole ﬁbril model. We will (ii) learn how speciﬁc cross-β core structures found in LBD and other synucleinopathies change the conformational ensemble and dynamics of the IDRs, and (iii) we will understand how these changes inﬂuence the interaction of speciﬁc binders, in our case DNAJB1. Together these advances will facilitate the development of new approaches to diagnose and treat LBD and ADRD.

Public health relevance
Narrative α-Synucleine aggregates into ﬁbrils in many neurodegenerative diseases such as Lewy body dementias (LBDs), multiple system atrophy (MSA), and Parkinson’s disease (PD). Understanding the molecular structure and dynamics of both the structured and unstructured parts of α-synuclein ﬁbrils will facilitate the development of new approaches to diagnose and treat these diseases.